Methods for survival processes arising in end-stage renal disease

PROJECT SUMMARY
Importance: There were over 700,000 end-stage renal disease (ESRD) patients receiving renal
replacement therapy dialysis in the United States at the end of 2015. ESRD has a substantial impact on
mortality, morbidity, health care cost and quality of life. The preferred therapy, kidney transplantation, is
in relatively short supply; e.g., less than 19,000 kidney transplants occurred in the U.S. in 2015, with
about 83,000 patients remaining on the wait list at year end.
Problem: Given that mortality and hospitalization rates are quite high among ESRD patients, flexible,
broadly applicable and easily implementable methods of analysis are required for modeling
hospitalization, death, and the two processes simultaneously. Existing methods either fail to target
quantities of interest in Aims 1-3 (below), or do so using strong assumptions which limit their applicability.
Overall Objective: The overarching goal of this project is to develop survival analysis methodology to
support analyses that will produce a deeper understanding of morbidity and mortality patterns among
ESRD patients. Such increased understanding should lead to improvements in renal replacement
therapy and, in turn, improved survival and quality of life among ESRD patients.
Target Audience: With respect to methodology, the target audience includes biostatisticians, particularly
practitioners studying ESRD and other chronic illnesses. Results based on the proposed analyses would
be of interest to nephrologists, transplant surgeons and ESRD patients.
Products: Novel and innovative methods for the analysis of survival and recurrent event data.
Specific Aim 1: Methods for alternating recurrent event data
Methods will be developed for analyzing alternating gap time data (e.g., time to readmission; length of
hospital stay). They will be applied to the Dialysis Outcomes and Practice Patterns Study (DOPPS).
Specific Aim 2: Simultaneously modeling state prevalence and survival
We will develop methods for jointly modeling state prevalence probability and survival. The methods will
be applied to SRTR data to analyze the probability of being active on the kidney transplant wait list.
Specific Aim 3: Instrumental variable (IV) methods based on restricted mean survival time (RMST)
Methods to estimate causal treatment effects on survival through IV analysis will be developed. The
methods will be applied to compare survival by dialytic modality using USRDS data.
For each Aim, the methods will be easily implementable since user-friendly software (SAS, R) will be
developed and made available online.

Public health relevance
RELEVANCE: The proposed project is relevant to public health in the United States since end-stage renal disease (ESRD) is associated with high mortality and morbidity, with the preferred treatment modality (kidney transplantation) being in relatively short supply. Moreover, ESRD prevalence has been increasing for some time in the U.S., a trend which would be expected to continue given the increased incidence of diabetes and the aging of the U.S. population. Our proposal is relevant to the National Institutes of Diabetes and Digestive and Kidney Diseases (NIDDK) since analyses based on the project's products (novel and innovative biostatistical methods) will lead to considerable advances in the understanding of ESRD morbidity and mortality patterns and hence, in turn, improve the health and quality of life of ESRD patients.